Project 1: Understanding the Evolution of Bladder Cancer from Field Effects

Project 1 – Summary
Bladder cancer is a common human malignancy related to tobacco smoking and exposure to chemical, industrial,
or environmental carcinogens. It develops from precursor lesions in the urothelial layer of the bladder along two
distinct tracts referred to as papillary and nonpapillary that represent clinically and molecularly different forms of
the disease. In this grant application, we propose to perform whole-organ, multiplatform genomic studies of
molecular profiles of bladder cancer development from early mucosal field effects through in situ preneoplastic
conditions to clinically evident aggressive disease. These studies will be complemented by in-depth
characterization of molecular mechanisms regulated by the forerunner (FR) genes lysophosphatidic acid
receptor 6 (LPAR6) and calcium-binding protein 39-like (CAB39L), which control urothelial differentiation. Our
preliminary data demonstrated that loss of their function, predominantly due to hypermethylation, dysregulates
basal to luminal urotheilal differentiation program. We hypothesized that early changes in microscopically
normal mucosa, referred to as field effects, dysregulate urothelial differentiation and contribute to bladder cancer
development. We will test this hypothesis in three specific aims: 1) characterize the evolution of the genomic
profile of bladder cancer from initiating field effects, 2) identify the biologic effects and molecular
pathways controlled by FR genes, and 3) identify the involvement of FR genes in molecular subtypes of
bladder cancer. When completed, this project will provide a detailed chronologic atlas of bladder cancer
evolution from mucosal field effects complemented by in-depth characterization of signature molecular
mechanisms initiating bladder carcinogenesis. Collaborative studies between Projects 1 and 2 will focus on the
role of luminal dysregulation controlled by nuclear receptors such as PPARG in the evolution of bladder cancer
from mucosal field effects and in bladder cancer cell lines as well as animal models exploring the role of
phenotypic luminal to basal plasticity in therapeutic response. Similarly, collaborative studies between Projects
1 and 3 will investigate the expression pattern of IFN target genes in the evolution of bladder cancer from mucosal
field effects as well as the role of luminal to basal plasticity in therapeutic response. The data generated by this
project will facilitate early bladder cancer detection and bladder cancer prevention and will identify novel targets
for therapeutic interventions. The Pathology Core will provide tissue and analytical assistance for all aims. The
Biostatistics and Bioinformatics Core will analyze the data for all aims. The Administrative Core will assist
with strategic oversight, regulatory issues, and communication with other projects and cores and the funding
agency.

Public health relevance
Project Narrative Bladder cancer is an ideal model of human carcinogenesis which permits the studies of early events initiating the development of malignant transformation in mucosal field effects. We propose to generate a chronologic atlas of urothelial cancer development from mucosal field effects to clinically evident disease based on multi- platform genomic analysis of the entire organ. These studies will be complemented by in depth analysis of signature molecular mechanisms contributing to early events of urothelial carcinogenesis controlled by forerunner genes (LPAR6 and CAB39L) dysregulating urothelial differentiation.